Investigating Neisseria gonorrhoeae double-stranded bacteriophage

Abstract
Neisseria gonorrhoeae is an obligate human pathogenic species. A few reports in the literature
describe three or four genomic islands encoding potential double-stranded phage genomes, and only one
manuscript reports the production of a double-stranded phage. However, there are issues with the rigor of that
report. We have also published that sublethal hydrogen peroxide treatment induces the expression of some
genes carried in these phage islands (Quillin, et al.-2018). Moreover, two saturating transposon screens failed
to isolate transposon insertions in some phage island genes (Hu, et al.-2020, Remmele, et al.-2014). We have
developed a CRISPR interference (CRISPRi) system for N. gonorrhoeae (Geslewitz, et al.-2024) and have
used it to show that repression of two of the three phage-island encoded LexA orthologs is lethal. Down-
regulation of one ortholog by CRISPRi results in the production of phage particles as assayed by transmission
electron microscopy. We will determine whether one or more phage islands can produce phage, explore
whether the two essential LexA orthologs are regulated similarly to the canonical LexA, and determine whether
these phage(s) can infect Neisseria strains or species.

Public health relevance
Narrative Neisseria gonorrhoeae is the primary causative agent of the sexually transmitted infection, gonorrhea. We have found that N. gonorrhoeae can produce bacterial viruses (bacteriophage) and are investigating the mechanisms that allow phage to produce and infect other bacterial cells.